Preclinical Efficacy and Intermediate Endpoint Biomarkers - Orientation Meeting

SRI International has been awarded as a prime contractor of RFP-N01-CN25002-78 entitled “Preclinical Efficacy and Intermediate Endpoint Biomarkers.” They are scheduled to attend the orientation meeting that is scheduled on October 22, 2012.